Building a kidney monitoring panel to guide therapy in resistant hypertension

PROJECT SUMMARY
Hypertension (HTN) is the most common risk factor for cardiovascular disease (CVD) and causes multiple
health problems including stroke, heart failure, kidney failure, myocardial infarction, and death. Resistant HTN
is defined by failure to reach blood pressure (BP) goal despite the use of 3 or more HTN medications. Among
the most challenging populations with resistant HTN to treat are persons with renal artery stenosis (RAS) since
HTN treatment in RAS often causes changes in creatinine (Cr). Furthermore, these individuals have extremely
high CVD risk, so achieving BP control is especially important. A major challenge that impairs HTN treatment is
the perception of worsening kidney function or acute kidney injury (AKI) based on creatinine (Cr) changes
during HTN treatment. Blood pressure lowering is often accompanied by changes in Cr, which in turn, typically
leads to interruption or cessation of effective HTN medications; this clinical response is harmful to patients
because these elevations in Cr are typically caused by benign accommodations to hemodynamic changes
rather than acute kidney injury (AKI). The goal of this proposal is to develop a better kidney health monitoring
system, a urine-based kidney tubule health panel (KTHP), that can adjudicate AKI vs. benign Cr changes
during HTN treatment, and thus address a critical unmet need. In Aim 1, we will determine whether KTHP
biomarkers predict the magnitude of BP lowering during treatment with a comprehensive and structured BP
lowering intervention. In Aim 2, we will determine if the magnitude of BP lowering is associated with changes in
KTHP markers at 1-year; and, we will evaluate associations of decreases in eGFR with the changes in the
intrinsic kidney damage markers (KTHP) at 1-year. These studies will provide critical insights into the
comparative utility of KTHP biomarkers vs. creatinine during BP lowering. In Aim 3, we will evaluate
associations of both baseline and changes in 1-year KTHP with CVD events. These Aims will be accomplished
by utilizing the rich and detailed clinical phenotyping of the Cardiovascular Outcomes in Renal Atherosclerotic
Lesions (CORAL) trial, including adjudicated clinical events. The CORAL trial biospecimen bank has baseline
and 1 year urine specimens that will allow for KTHP biomarker assessment. The methods in this proposal will
build on our prior work in the SPRINT trial and will validate the KTHP biomarkers in a high-risk HTN cohort with
frequent changes in Cr during BP lowering treatment. Together, these studies will provide detailed
investigation of urine KTHP biomarkers for monitoring during treatment of resistant HTN. Overall, we aim to
improve or replace the current Cr-based kidney health monitoring system, and to prove the accuracy and utility
of the proposed KTHP biomarkers for monitoring during both resistant and general HTN treatment.

Public health relevance
PROJECT NARRATIVE Changes in kidney health are believed to be common during medical treatment to lower blood pressure because clinicians use an antiquated monitoring approach based on blood creatinine levels. This research proposal will develop and evaluate an improved method for assessing kidney health based on urine proteins that originate within the kidneys. Our goal is to change the paradigm for kidney health monitoring and allow more people to achieve hypertension control and healthier lives.